Omics Core

The primary function of OMICS Core is to provide members of the University of Louisville Alcohol Research
Center (ULARC) with the expertise, resources, and facilities needed for metabolomic, proteomic, and
bioinformatic analyses of biological samples collected to study nutrition, gut flora/intestinal dysfunction and
alcohol-induced organ injury, and therapeutic interventions. OMICS Core personnel will assist with the design
of sample collection protocols, will drive the development and the execution of novel and robust
chromatographic methods for sample separation and mass spectrometric methods for the analysis of proteins,
peptides and metabolites with a goal of providing a greater understanding of the evolution of molecular
mechanisms that correlate with or participate in liver dysfunction. OMICS Core will ensure uniformity and
standardization in sample preparation, method development, instrument performance, data collection, data
reporting, and data sharing. OMICS Core endeavors to contribute to the overall success and utility of the
ULARC and to enhance the infrastructure and the technical and academic capabilities of the institution as a
whole. OMICS Core will also promote the education and training of the ULARC members with regards to the
state-of-the-art omics technologies. Furthermore, OMICS Core will become an independent and self-
supporting entity using a set comprehensive approaches that have been already been implemented and have
demonstrated their success in our current ULARC. The OMICS Core is projected to provide necessary and
essential support to all ULARC projects.